Targeting Sex Hormone Receptors for Treatment of Meibomian Gland Dysfunction

Project Summary/Abstract
The tear film on the ocular surface provides a protective barrier and serves as physiological lubricant to the
ocular surface for ocular comfort and visual clarity. A lipid layer produced by the Meibomian glands (MGs) in
the inner surface of eyelids constitutes the outermost layer of the tear film, with its function to prevent the
evaporation of aqueous tear secreted by the lacrimal glands. Meibomian gland dysfunction (MGD) is the most
prevalent cause of dry eye disease (DED) in the world with significant socioeconomic impact and public health
concerns. To date, treatments for MGD or DED are mostly palliative for temporary symptom relief without
targeting to improve MG function and abnormal evaporative loss of tears. It is well recognized that older age
and female sex are the two significant risk factors for developing MGD and DED, although the prevalence
varies widely among different age groups and sexes. For years, sex hormones have been postulated to play
an important role in the maintenance of a normal tear film and ocular surface health. Like the related
sebaceous glands (SG) of the skin, androgens are known to increase lipid synthesis and enhance the MG
function. In contrast, a higher serum estrogen level was a significant predictor of worsening MG function in
women. However, this consensus is unable to explain the higher prevalence of DED in postmenopausal
women whose estrogen levels are reduced. In our preliminary study using estrogen receptor (ER) knockout
(KO) mice, we found that loss of ER isoform α (ERα), but not ERβ, markedly increased the androgen receptor
(AR) in the acinar cell nuclei of the meibomian glands in female KO mice. This finding suggests a crosstalk
regulation at the hormonal receptor levels, i.e. ERα has an antagonistic effect on AR nuclear translocation in
female MGs. In this application, we propose a new therapeutic target for MGD treatment by increasing the
lipogenic function of AR via ER suppression. Up to date, a battery of pharmacological ER inhibitors has been
widely used to block ER activity in ER+ breast and other cancers with satisfactory efficacy and clinical safety
profiles. We will explore the therapeutic implications of two popular ER inhibitors, tamoxifen (a selective ER
modulators or SERM) and fulvestrant (a selective ER downregulator or SERD) for better management and
treatment of MGD. In Aim 1, ER inhibitors will be administrated systematically to suppress ER-related activity
in wild type (WT) mice, a condition resemblance of ERα deletion in KO mice. It’s expected that treatment by
ER inhibitors will augment AR activity and increase lipogenesis in the MGs of female mice. In Aim 2, a
combined treatment of androgen and ER-inhibition is proposed to evaluate whether elevation of both androgen
and AR can circumvent age-associated hormonal decline and maintain or restore MG function in aged mice.
The outcomes from this proposal will establish a brand new therapeutic paradigm in targeting the regulation of
sex hormones and their receptors for MGD and pave the avenue for a potential investigational new drug (IND)
application of using currently available ER inhibitors for age-related MGD in postmenopausal women.

Public health relevance
PROJECT NARRATIVE Meibomian gland dysfunction (MGD) is the most common form of evaporative dry eye disease (DED) and can affect millions of people leading to eye discomfort and/or damage to the ocular surface with potential vision loss. Sex and sex hormones are known to affect the functions of tear-producing glands, including the meibomian glands (MGs), and contribute to the difference in DED prevalence between women and men. The proposed study is to investigate whether modulating the levels of sex hormone receptors by pharmacological agents can improve the MG function for targeted treatment of age-related MGD.